Role of Host Filamin Proteins in Regulating Filovirus Entry and Egress

Filoviruses (Ebola [EBOV] and Marburg [MARV]) are zoonotic, emerging pathogens that cause sporadic and
global outbreaks of severe hemorrhagic fever in humans and non-human primates. As EBOV and MARV can
establish persistent infections in the CNS, semen, eye, and other immunologically privileged sites inaccessible
to antibody therapy, and their re-emergence can result in long-term sequelae and death, understanding of host
defense mechanisms that could lead to the development of new antiviral therapies is more critical than ever. Our
lab is at the forefront of identifying host proteins that interact both physically and functionally with the filovirus
VP40 matrix protein, the driving force for virus assembly and egress, to regulate these late stages of virus
replication. To better understand the functional filovirus-host interactome, our laboratory has focused on direct
interactions between the PPxY Late (L) domain motif conserved in the VP40 proteins of EBOV (eVP40) and
MARV (mVP40) and modular WW-domains from select host proteins. In addition to positive regulators of filovirus
egress, we have recently identified WW-domain interactors that negatively regulate VP40-mediated budding,
including YAP/TAZ, BAG3, and WWOX. While the impact of these negative regulators is likely multifactorial and
complex, we have made the intriguing observation that filamin B, a common downstream effector of YAP/TAZ
and BAG3, acts as a potential dual regulator of live EBOV/MARV infectivity/entry and live EBOV/MARV egress.
As dual role regulation of key stages at opposite ends of the filovirus lifecycle is novel and unexpected, the
ultimate goal of this proposal is to determine how host protein filamin B mechanistically impacts the filovirus
lifecycle. Filamins are a family of actin crosslinking/stabilizing proteins that regulate actin dynamics at the plasma
membrane to control cell migration and morphology, vesicle trafficking, macropinocytosis, and cell division.
Notably, macropinocytosis
macropinosomes
is
(MPs) that are densely coated with actin, filamin, and filamin-associated proteins
a key entry pathway for filoviruses, as these viruses enter the cell in vesicles
termed
. In addition,
filamins are linked to cellular processes that mimic virion formation and/or egress such as filopodia formation,
cell migration, and cytokinesis. Thus, we hypothesize that filamin B regulates infectivity/entry of filoviruses
through effects on macropinocytosis, and regulates filovirus budding through effects on egress of filopodia-like
filovirus particles. In this exploratory proposal, we propose to investigate the mechanisms by which filamin
regulates filovirus infectivity/entry (Aim 1) and egress (Aim 2). Results from these studies will impact the field by
identifying a novel host protein(s) whose expression modulates two critical and opposite steps in the filovirus
lifecycle; entry and exit, as well as providing a better fundamental understanding of the functional filovirus-host
interactome and host defense mechanisms that could lead to the development of new antiviral therapies.

Public health relevance
Narrative: We identified host protein filamin B as a novel regulator of both entry and exit of Ebola and Marburg viruses from mammalian cells. Here we seek to determine the molecular mechanism by which filamin B modulates these steps in the virus lifecycle. These studies will enhance our understanding of key virus-host interactions at the molecular level, which may lead to the development of new antiviral strategies to combat these infections.